Inhibition of NF1 Protein Degradation as a Treatment for NF1 Haploinsufficiency

PROJECT ABSTRACT. Haploinsufficiency plays a crucial role in Neurofibromatosis (NF1), an autosomal
dominant genetic disorder impacting over 120,000 Americans. Current therapeutic approaches target
downstream components of NF1 signaling, for example MEK inhibition in tumors, thus failing to address the
broad range of signaling and symptoms associated with NF1 mutations. Given that NF1 is characterized by
both autosomal dominance and haploinsufficiency (lack of normal protein), inhibiting NF1 protein degradation,
causing a net increase in NF1 protein, has the potential to alleviate a broad range of NF1 symptoms and halt
overall disease progression. Infixion proposes to identify and validate genes involved in NF1 protein
ubiquitination and degradation, and to build a protein-tagged reporter assay to screen the impact of known
drugs on NF1 protein levels, with a focus on modulators of NF1 protein degradation. By identifying candidate
drugs inhibiting NF1 ubiquitination, we target an increase in overall NF1 protein, and thus a normalizing of Ras
(and other) pathway signaling in individuals with NF1. We propose this as a novel path of NF1 drug discovery,
with potential impact on a broad range of NF1 patients and symptoms, in a preventative manner, and
applicable to the very wide spectrum of unique NF1 genetic mutations.
Research Background. Increasing NF1 expression via transfection reverses abnormal Ras activation
resulting from NF1 loss (Wallis, 2018; Mellert, 2018). Increased protein expression in other genetic conditions
such as Willams-Beuren Syndrome, and Supravalvular Aortic Stenosis compensates for haploinsufficiency
(Giordano, et al. 2012). Lastly, overcoming haploinsufficiency in other autosomal dominant conditions (Sim1;
Pax6 genes) have shown an ability in vivo to correct symptoms. (Matharu, et. al. 2019; Rabiee, et. al. 2020).
Specific Aims. 1) Identify regulators of NF1 protein stability using siRNA libraries as a genetic (knock-down)
screen in NF1-relevant cell types. Identifying regulators of NF1 ubiquitination and subsequent degradation will
allow for rational selection of additional libraries to screen for compounds to increase NF1 protein. 2) Construct
an assay, engineering the endogenous NF1 gene to tag the NF1 protein, in a well characterized, publicly
available (ATCC), immortalized NF1 +/- Schwann cell line. Validate assay using compounds already verified by
Infixion to increase NF1 protein levels. 3) Deploy NF1 protein stabilization assay to screen a 13,000+
compound repurposing library of known drugs available from Scripps Research Institute (known as ReFrame),
and other targeted libraries. The top hits from these screens will be evaluated utilizing immortalized Schwann,
primary fibroblast and iPSC derived NF1+/- cells, for the following: a) ability to induce NF1 protein expression
using Westerns/ELISA, b) impact on Ras signaling (pERK, ELK-1, AKT, etc.) utilizing a targeted quantitative
mass spec proteomics assay, c) impact on cell proliferation, and d) safety profile based on published data.
Program goal is to prioritize 3-5 candidate compounds for an SBIR Phase 2 pre-IND evaluation.

Public health relevance
Project Narrative Neurofibromatosis Type 1 (NF1) is an autosomal dominant genetic disorder that impacts an estimated 1 in 3000 people worldwide, and characterized by a complex set of symptoms shown to be highly dependent on protein haploinsufficiency (i.e., the lack of normal NF1 protein). By increasing NF1 protein levels, and thus restoring normal levels of functional NF1 protein in tissues important in NF1 pathology, we target a range of NF1 symptoms by eliminating the haploinsufficient environment. We propose to develop and utilize an NF1-specific assay using luciferase-tagged protein in Schwann cells, along with standard small molecule evaluation tools, to characterize a small molecule library of repurposed drugs for their ability to modulate protein degradation caused by ubiquitination, and to further evaluate the impact of “hits” on NF1 protein expression, cell proliferation, as well as downstream pathways (such as Ras, MEK, mTOR, cAMP, and HCN1) known to be dysregulated by mutations in the NF1 gene.